NCI SUPPORT FOR THE GENOMICS ROUNDTABLE

In 1997, the Division of Cancer Control and Population Sciences was established to enhance NCI’s ability to alleviate the burden of cancer through research in epidemiology, behavioral sciences, health services, surveillance, and cancer survivorship. Cancer control research aims to generate basic knowledge about how to monitor and change individual and collective behavior, and to ensure that knowledge is translated into practice and policy rapidly, effectively, and efficiently.